Lens epithelial cell heterogeneity during development

The proliferation, differentiation and homeostasis of lens anterior monolayer epithelium determine
the lens growth, size, shape and transparency, which are absolutely required for focusing and
transmitting a light image onto the retina. The goal of this proposal is to test a novel hypothesis
that the intrinsic heterogeneity of lens epithelial cells regulates lens growth and homeostasis,
and distinctive cell clusters of lens monolayer epithelium are precisely organized for mediating
external signals of surrounding ocular tissues and environmental stimuli to regulate the lens
growth, size, shape and transparency, and that disruptions of specific cell cluster(s) impair the
regulation of lens growth and homeostasis to lead to various lens and/or eye pathological outcomes
including cataracts, microphthalmia, and macrophthalmia.

Public health relevance
This study aims to investigate the molecular and cellular bases of the heterogeneity of lens epithelium that consists of distinct cell clusters with different functions. Moreover, we will explore novel regulatory mechanisms of distinct epithelial cell clusters in lens growth control, lens homeostasis maintenance and various lens pathological outcomes. We will gain insights into fundamental mechanisms about how distinct epithelial cell clusters selectively response to various external stimuli to regulate the lens size and homeostasis over the course of postnatal lens development and aging.